Admin-Core

PROJECT SUMMARY: ADMINISTRATIVE CORE
The Center for Methodologies for Adapting and Personalizing Prevention, Treatment, and Recovery Services
for SUD and HIV (MAPS Center) will develop, translate, and disseminate novel experimental and data analytic
methods to optimize adaptive interventions in substance use disorders (SUD) and HIV services. The overall
purpose of the Administrative Core is to oversee all activities of the MAPS Center and ensure the Center as a
whole meets the Center-wide overall specific aims. This Core will maintain the MAPS Center's administrative
infrastructure to keep the Center running smoothly; facilitate communication and promote synergy among all
MAPS Center investigators, staff, and sites; lift much of the administrative and regulatory burden from
investigators; support and facilitate the scientific mission of the Center; and obtain input from well-qualified
experts on the Center's efforts and activities. The Administrative Core will organize and coordinate all
research, dissemination, and training activities via three Specific Aims: (Aim 1) To promote productive
communication and synergistic collaboration among MAPS Center investigators and between MAPS Center
investigators and other SUD/HIV scientists working in prevention, treatment, and recovery services — this
includes facilitating innovative center-to-center collaborative partnerships with four well-established, NIH-
funded groups that have distinguished records of productivity in behavioral SUD/HIV research; (Aim 2) To
enhance the productivity of MAPS Center investigators by facilitating the organization, monitoring, tracking,
and reporting of financial and regulatory compliance activities; and (Aim 3) To ensure the MAPS Center
becomes a national resource for innovative and high-impact experimental and data analysis methods for
adaptive interventions in SUD/HIV prevention, treatment, and recovery services. This Core will work in concert
with the Dissemination and Training Core to implement the MAPS Center's multifaceted dissemination strategy
and to ensure that it is effective in its efforts to foster the next generation of SUD/HIV scientists and
methodologists equipped to optimize adaptive SUD/HIV services. This Core also will convene meetings of a
distinguished external advisory committee to guide the MAPS Center's scientific mission and activities and will
coordinate the MAPS Center efforts to promote diversity, equity, and inclusion. The Administrative Core will
ensure the MAPS Center operates efficiently, maximizes its productivity, brings new scholars and ideas to the
Center and to the field, and fosters continuing methodological improvements to adaptive interventions focused
on SUD/HIV prevention, treatment, and recovery services.